Structural regulation of Class-I and Class-II cytochrome P450 enzymes

Project Summary and Abstract
Cytochrome P450 enzymes (CYPs) are responsible for a multitude of critical biological
transformations, including, but not limited to reactions central to vitamin-D and cholesterol
metabolism, steroidogenesis, fatty acid metabolism, and early-stage drug metabolism. In work
supported by our ESI MIRA, we addressed three significant questions in this field. First, we
demonstrated that proper coordination of substrates, located distal to the active site heme, can
influence the molecular recognition of the necessary CYP redox partner proteins along the
proximal side of the enzyme. Second, we demonstrated that such long range allostery is
bidirectional, thus redox protein recognition can also influence CYP-substrate interactions. Lastly,
we demonstrated that the route that constitutes distal-to-proximal allostery is conserved across
structurally homologous mammalian and bacterial CYPs. Together, these contributions provide
the necessary framework for understanding novel modes of structural regulation in this important
class of enzymes. In the proposed MIRA, we will use our biochemical and biophysical
experimental workflow to expand these findings into three broad Program Areas. These include i)
an investigation of the regulatory potential of mitochondrial CYP-Adrenodoxin encounter
complexes, ii) an investigation of drug-induced modulation of CYP-reductase interactions, and iii)
elucidation of a pH-sensing mechanism in CYPs. This work represents an expansion of the scope
of the ESI MIRA, while also advancing the field by exploring novel modes of structural regulation
of CYP function.

Public health relevance
Project Narrative: Cytochrome P450 enzymes perform necessary functions in the maintenance of basic human health, including regulating levels of important endogenous hormones and steroids, as well as playing an important role in drug metabolism. In this proposal, we seek to use biochemistry and biophysics to apply the insights gained from our recent findings to address practical questions revolving around cytochrome P450 enzymes that have a direct relevance to human health and disease.